Alpha Adrenergic Methylation and Developmental Maturation of Cerebral Autoregulation in Ovine Preterm Fetus

Summary: Preterm infants have a significantly higher incidence of brain damage as a consequence of immature cerebral
blood flow (CBF) autoregulation. In contrast to term neonates, preterm neonates are not able to reduce CBF in response to
increased systemic BP. In preterm neonates, exposure of fragile cerebral vessels to an increased amount of blood flow at
elevated systemic pressure leads to their rupture and brain damage. Our preliminary studies demonstrate that near-term
fetuses and term-newborn lambs can constrict carotid arteries and reduce CBF when systemic BP rises; however, this
capability is not developed in the preterm fetus. Also, we observed that following the removal of sympathetic control in the
near-term fetus by severing the superior cervical ganglion made them lose their ability to restrict carotid blood flow to the
brain with the rise in systemic BP. We also observed that the constriction of carotid arteries to reduce CBF is regulated by
the sympathetic nervous system, specifically by the activity of alpha-1 adrenergic receptors (α1-ARs). These receptors are
expressed at a significantly lower number in preterm carotid arteries. Thus, we concluded that reduced activity of α1-ARs
plays a fundamental role in regulating carotid blood flow with the rise in systemic BP. Furthermore, we present evidence
that differential DNA methylation regulates α1-ARs promoter activity and expression. Thus, we will test the hypothesis that
DNA methylation and demethylation regulate the expression and function of α1-AR subtypes (α1A-, α1B-, α1D) in the carotid
arteries and play a crucial role in the maturation of CAR from preterm to term fetus. We will collect data from both sexes
to identify any sex-related changes. The studies will be conducted in-vivo in chronically catheterized fetal sheep and ex-vivo
on isolated carotid arteries. The hypothesis will be tested with two specific aims. Aim 1: From preterm to term fetus in a
sex-specific manner, we will conduct an in-depth mechanistic analysis of promoter DNA methylation on differential
expression of α1-AR subtypes in carotid arteries. Aim 2: In a sex-specific manner, we will determine the functional
significance of differential α1-AR subtypes promoter methylation and expression on carotid artery contractility and blood
flow. The measurements will be conducted in real-time, in-vivo, with in-utero fetal maturation. This will provide valuable
information regarding the role of α1-AR subtypes and the epigenetic mechanisms involved in the maturation of CAR.

Public health relevance
Narrative: The brain damage is far too common in the preterm neonates. The proposed research will identify the mechanism to prevent brain damage in the preterm neonates. The research will be conducted in vivo in the preterm fetus to identify therapeutically relevant targets to control blood flow to the brain.